Reprogramming Macrophages to Improve Vascular Healing in Diabetes

Impaired wound healing in US veterans with diabetes mellitus is a major source of morbidity and mortality as
well as a large financial strain on the VA health care system. Current treatment paradigms, including
debridement of necrotic tissue, infection control, local ulcer care, mechanical off-loading, and management of
blood glucose levels, are modestly effective at best. Despite much research in this area, the critical molecular
mechanisms regulating angiogenesis-directed wound healing remain minimally defined. Recently, our group
identified an important role for early inflammatory macrophage VEGF-A production in promoting consequent
angiogenesis/ arteriogenesis required for adequate wound healing. We determined macrophage proangiogenic
VEGF-A isoform transcription to be dependent on autocrine IL-1β-IL-1R signaling through activation of nuclear
NF-κB and binding of NF-κB to the VEGF-A promoter region. Analogous to macrophage IL-1β-deleted mice,
mice with experimental diabetes demonstrated impaired tissue proangiogenic VEGF-A expression and
consequent reductions in wound healing and arteriogenesis. Under inflammatory conditions, bone marrow
derived macrophages (BMDMs) from diabetic mice expressed reduced VEGF-A consistent with reduced
signaling response to IL-1β, and interestingly, there is reduced expression of several key IL-1R signaling
complex components, suggesting an impaired responsiveness to IL-1β. Our working model is that DM
uncouples IL-1R signaling from VEGF-A transcription, causing impaired proangiogenic VEGF-A expression
and consequent decreased angiogenesis-based healing. In this VA Research Supplement to Promote Diversity
proposal, we seek to reactivate macrophage VEGF-A expression by effectively bypassing IL-1R signaling and
upregulating NF-κB activity directly. The primary hypothesis is that rescue of DM-mediated impairments in
VEGF-A-dependent angiogenesis via direct upregulation of NF-κB activity is a viable therapeutic angiogenesis
strategy for wound healing. We aim to 1) demonstrate that myeloid expression of constitutively active IKK-2
can rescue proangiogenic VEGF-A expression and VEGF-A-dependent angiogenesis in the context of
macrophage IL-1R-deletion; and 2) demonstrate that BMDMs programed to express constitutively active IKK-2
are sufficient to increase wound healing angiogenesis and arteriogenesis using mice with experimental DM. By
manipulating mechanistic pathways downstream of IL-1R signaling-dependent VEGF-A expression to
therapeutically reactivate diabetic macrophage angiogenic and wound healing responses, we will validate a
therapeutic angiogenesis strategy that has tremendous potential to impact the lives of US veterans and all
Americans. Moreover, this proposal serves as a robust training platform for Dr. Roberto Mendez, a Mexican
American and US veteran, who is committed to developing a VA-based research career focused on veteran
health. These studies will provide him with important preliminary data to support his own VA CDA-1 application
proposal within the next two years.

Public health relevance
Diabetes is a common chronic disease in the US veteran population, and non-healing skin wounds are a major cause of loss of limb and debility for veterans with diabetes. Current medical treatments have limited effectiveness at healing wounds because it is not entirely clear how diabetes impairs the healing process. The primary goal of these studies is to activate inflammation signals that direct the early growth of new blood vessels to help with healing. We believe these studies will lead to new therapies that promote more effective skin healing and limb salvage for veterans and all patients with diabetes.